Genomic Analysis of Tissue and Cellular Heterogeneity in IPF

PROJECT SUMMARY
Idiopathic Pulmonary Fibrosis (IPF) is a chronic progressive lung disease with significant morbidity and
mortality. In the previous period of this grant, we performed bulk RNA-seq and microRNA profiling of microCT
defined differentially affected lung regions. This work led to identification of numerous molecular targets and
insights, development of computational methods, and development of a transcriptional model of fibrosis
progression. Using the powerful high-resolution technologies of single cell profiling, we generated a ‘map’ of all
human cells in patients with IPF, discovered novel, ectopic and aberrant cell populations, and replacement of
the distal alveolar cellular content with cells that usually populate the airways. These exciting findings are
foundations of this renewal application that focuses on identification of the signals that drive the changes we
identified, their sequence and their spatial organization. The hypothesis underlying this application is that
the unique histopathologic features of IPF reflect a disruption in the homeostatic cellular networks in
alveolar niche, that activates an aberrant but coordinated repair process that leads to the proximalization
of the distal lung. To address this hypothesis, we have assembled a multi-disciplinary team of experts in lung
fibrosis, genomics, proteomics, computational biology, computer science, cell and molecular biology, statistics,
imaging, bioengineering, pathology, and bioinformatics that will perform the following specific aims:
Specific Aim 1: To identify the specific sequence of changes in cell compositions and phenotypes during the
progression of fibrosis in the human IPF lung.
Specific Aim 2: To identify the changes in spatial relations, interactions, and connections between cellular
members of the fibrotic niche at different stages of fibrosis and progression of fibrosis.
Specific Aim 3: Generation of a systems biology model of human pulmonary fibrosis with a specific focus on
regulators of disease emergence and progression.
At the completion of this project, we will have a cell level, comprehensive transcriptional regulatory,
mechanistically relevant model of IPF based on the unique histological features of the disease. The model, the
discovered key regulatory modules and the accompanying data sharing, and dissemination tools will be useful
for understanding disease mechanisms and generation of novel, effective and precise therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is a chronic progressive lung disease with significant morbidity and mortality. The overall objective of this application is to apply the principles of systems biology to create, refine and validate a cell specific causal model of IPF emergence and progression in the human lung and thus transform our ability to design effective interventions.